Data Coordinating and Operations Center for the ECHO IDeA States Pediatric Clinical Trials Network

Project Summary
Many children, particularly those in rural and underserved communities, lack vital access to pediatric clinical
trials. This project addresses this disparity by proposing a Data Coordinating and Operations Center (DCOC)
for the NIH Environmental influences on Child Health Outcomes (ECHO) IDeA States Pediatric Clinical Trials
Network (ISPCTN), a national leader in this field. The project acknowledges current challenges faced by these
communities, including geographical limitations, lack of trusted local information, logistical hurdles, and
healthcare providers unfamiliar with conducting clinical trials. The proposed ISPCTN DCOC at the University of
Kansas Medical Center (KUMC) in partnership with the University of Nebraska Medical Center (UNMC) aims to
bridge this gap by leveraging the complementary expertise of both institutions. The KUMC-UNMC DCOC will
actively support clinical trial activity by facilitating development, conduct, and results dissemination of
multicenter trials focused on rural and underserved children. Additionally, the DCOC will empower researchers,
clinicians, and community stakeholders in IDeA states by providing them with the necessary training and
support to build their pediatric clinical research capacity. Finally, the project emphasizes the importance of
community engagement. The DCOC will foster collaboration with communities, along with nonprofit and
professional societies, to ensure that clinical trials are culturally relevant, rigorously designed, and have a
significant impact on child health outcomes. The KUMC-UNMC DCOC will build upon the outstanding
foundation of policy and procedures developed in the first two cycles of the network to further increase
academic productivity and enhance the identification, development, execution, and results dissemination of
high quality pediatric clinical trials in these areas. The DCOC will integrate Quality by Design; continuous
quality improvement; real-time goals, objectives, indicators, and targets monitoring; multi-faceted professional
development; community research engagement and literacy; and learning collaborative approaches to ISPCTN
clinical trial operations and capacity-building. This initiative promises to increase access to clinical trials for a
wider range of children, while strengthening pediatric research capabilities in underserved areas. Ultimately,
the goal is to deliver high-quality, culturally sensitive clinical trials that generate valuable knowledge and lead to
improved health outcomes for children across the United States and beyond.

Public health relevance
Project Narrative Building on the ECHO IDeA States Pediatric Clinical Trials Network’s foundation, the University of Kansas Medical Center-University of Nebraska Medical Center Data Coordinating and Operations Center (DCOC) proposes to increase academic productivity, improve trial quality, expand access to ISPCTN trials for underserved children, and ultimately deliver impactful results for children's health. This initiative directly addresses a public health disparity by increasing participation in pediatric research, leading to more effective treatments and improved health outcomes for these vulnerable populations. By fostering community engagement and culturally relevant trials, the DCOC aims to ensure all children benefit from medical advancements.